Geographic Disparities in the Availability and Accessibility of Coordinated Specialty Care Programs for Early Psychosis

ABSTRACT
Coordinated specialty care (CSC) is the standard of care for early psychosis in the US. Supported by the 5-
10% set-aside in the Community Mental Health Block Grant program, targeted at evidence-based early
interventions, approximately 350 CSC programs have been implemented in 49 states across the US.
Neighborhoods where individuals reside are important determinants of health and the majority of the extant
work on neighborhood-level determinants and early psychosis has focused on the impact on individual-level
factors such as the incidence and onset of psychosis, and duration of untreated psychosis, but very few
studies have examined neighborhood-level characteristics as barrier to seeking services for early psychosis.
Research has highlighted the importance of mental health services being available in proximity
to an individual’s community, yet very little is known about the spatial distribution and accessibility of CSC
programs in the US. There is a clear gap in what we know about the potential difficulties accessing CSC
programs and whether the geographical placement and distribution of CSC programs contributes to
inequities. To address this gap, our overarching goal of the proposed study is to characterize CSC programs
and understand the geographical distribution and inequities in access to CSC programs. We will create
a novel integrative multi-level geospatial database of CSC programs implemented throughout the US, that
will include client-level data (race, ethnicity, age, gender), program-level data (geocoded location, capacity,
size, setting, payment, role availability), provider-level data (race, ethnicity, professional credentials), and
neighborhood-level census data (residential segregation, ethnic density, area deprivation, rural-urban
continua, broadband internet subscription, public transit time). Our specific aims are to 1) Characterize the
variations in facility-level characteristics of CSC programs by geographical location; 2) Examine geographic
availability and accessibility of CSC programs based on neighborhood-level characteristics; and 3) Develop
an interactive dashboard, using web-mapping technology, that will enable decision makers and community
stakeholders to identify areas with poor access to CSC programs. The proposed research represents a novel
application of advanced spatial analytics that will advance understanding on geographic inequities and
accessibility of CSC programs, which can used to inform policy and the future implementation of CSC
programs in high-need areas with limited access.

Public health relevance
PROJECT NARRATIVE The proposed study is highly relevant to public health because it examines the extent to which health disparity populations have access to the standard of care for early psychosis, coordinated specialty care programs, and whether access to services vary based on neighborhood-level characteristics. Due to the widespread dissemination of coordinated specialty care programs throughout the US, the examination of whether youth and families have equitable access to such services is the first step. Given the documented disparities in service utilization and difficulties experienced along the pathways to coordinated specialty care, the present study is critical to understanding these inequities, and aligns with NIMH strategic goals.